Analysis Core

ABSTRACT
The Analysis Core (AnC) will provide intellectual and technical support for new and alumni SD AD-RCMAR
Scientists. The AnC will provide extensive training in the skills, knowledge, measurement tools and data
resources needed to facilitate their research productivity (i.e., scientific presentations, manuscript publications,
and grant submissions), a requirement for becoming independent career scientists who can compete
successfully for external funding to further advance research in Alzheimer’s Disease and Related Dementias
(ADRD). In addition to providing training and support for the collection of primary data for new quantitative and
qualitative studies focused on addressing ADRD inequities through novel research targeting multilevel factors
to inform interventions focused on Hispanics/Latinos, limited English proficient (LEP) adults, and refugee
communities, the AnC will a) facilitate access to, ensure understanding of, and provide assistance in analyzing
new and diverse, secondary data sources, which can provide an efficient and rapid means for scholars to
increase their research productivity and scientific impact, and test new innovative hypotheses at low cost; b)
provide the AD-RCMAR Scientists with a strong background in social epidemiology methods and tools and
contextual and environmental metrics that can be merged with data from numerous cohort studies and
surveillance datasets to understand the drivers of inequalities in ADRD and opportunities to reduce them; and
c) provide support in the implementation of objective measures of health behaviors, culturally appropriate and
psychometrically valid tools, and cutting-edge, culturally-informed, and scientifically-valid approaches for
qualitative studies across diverse populations. These resources will be used to support the Scientists in
conducting research to illuminate the role of multi-level factors that may be modified to prevent ADRD and
enhance healthy cognitive aging in diverse populations.
The AnC will also work together with other SD AD-RCMAR Cores to support the AD-RCMAR Scientists in the
completion of their research, education, and career goals to ensure their continued trajectories towards
becoming independent investigators, and with the Coordinating Center to create, identify, catalog, and
disseminate scientific information regarding novel methodological developments, measurement approaches, or
new data resources produced by the SD AD-RCMAR.